CNS Mechanisms of IC/BPS

Abstract
Interstitial cystitis/Bladder Pain Syndrome (IC/BPS) is a serious and painful condition of unknown etiology that
affects 6% of women in the United States. The major clinical symptoms of IC/BPS are pain on bladder filling and
increased urinary urgency and frequency. The majority of IC/BPS patients (90%) also suffer from comorbid
anxiety and/or depression, contributing to a poor quality of life. Current available treatments for IC/BPS are
largely ineffective, providing only mild symptomatic relief. Given the prevalence of this debilitating disease and
the lack of effective treatments, further studies are needed to better understand the underlying mechanisms that
contribute IC/BPS and those that mediate the high incidence of comorbid anxiety and depression. We previously
reported that IC/BPS patients show referred abdominal hyperalgesia, a clear sign of central sensitization. In the
previous funding period, we used the single nucleus RNA sequencing, spatial transcriptomics and in situ
hybridization and identified two populations of CeA neurons that are activated in cystitis and appear to play
opposing roles in the regulation of bladder pain. Here we will apply state of the art approaches in systems
neuroscience to unravel the potential role of these unique neuronal subpopulations in the CeA in the reciprocal
regulation of pain, voiding dysfunction, and negative affective behaviors (IC/BPS-like conditions). What are the
respective roles of the two populations in bladder pain? Are the apparent pro- and anti-nociceptive actions of the
Pde1c and Cartpt populations, respectively, restricted to referred hypersensitivity, or do they also reciprocally
regulate ongoing pain? Do these populations play differential roles in the regulation of voiding behavior and
negative affective behaviors? What are the critical inputs to and projections from these neurons? Do these
populations undergo plasticity differentially in the induction and maintenance of cystitis? How do the dynamics
of this circuit change as cystitis resolves? Here we propose to answer these questions in a series of studies that
test the central hypothesis that maladaptive plasticity in these unique subpopulations of CeA neurons regulates
voiding dysfunction, pain sensitization, and comorbid negative affect in models of cystitis. These studies will
provide new insights into the critical role of the pro- and anti-nociceptive neurons in the CeA in bladder pain and
comorbid affective disorders in the context of bladder pain syndrome. If successful, these studies will point the
way to identifying pharmacological approaches to restore normal circuit function around these neurons to provide
relief from bladder pain, voiding dysfunction, and comorbid anxiety and depression in patients with IC/BPS.

Public health relevance
Narrative This proposal seeks to identify changes in the brain that are lead to the development of pain, urinary urgency, and comorbid anxiety and depression that are very often observed in patients with interstitial cystitis/bladder pain syndrome (IC/BPS). IC/BPS is a serious and painful condition that affects 3-6% of women in the United States. Understanding alterations in brain circuits can help us to design new treatments for IC/BPS.